A Novel Approach to Treating Glioblastoma through Activation of the Liver X Recep

PROJECT SUMMARY/ABSTRACT Glioblastoma multiforme (GBM) is characterized by major alterations in cellular metabolism, increasing their uptake and utilization of glucose coupled to enhanced lipogenesis and cholesterol uptake to meet the coordinately elevated anabolic and energetic demands imposed by rapid tumor growth. These metabolic alterations and the signaling pathways that control them, appear to be direct consequences of the genetic alterations that drive tumor growth and progression, thus providing a new array of potentially more specific and efficacious drug targets. We have recently demonstrated that amplification of the epidermal growth factor and its mutant form, EGFRvIII, up-regulate the expression of the low-density lipoprotein receptor (LDLR) to promote uptake of massive amounts of cholesterol into the cell; a process which is required for tumor growth and survival in vivo. We also showed that the Liver X Receptor (LXR), a critical determinant of LDLR levels, is a compelling novel therapeutic target in GBM. This proposal is designed to test a new, brain-penetrant LXR agonist, LXR-623 as a potentially potent, highly-specific anti-GBM therapy. We present exciting preliminary showing that LXR-623, potently kills every GBM cell line we have tested, while having no effect on normal human astrocytes, and we have demonstrated that this anti-tumor activity is mediated, at least in part, by up- regulation of the ATP-Binding Cassette Transporter 1 (ABCA1) to efflux cholesterol from the cell, and by up- regulation of the Inducible Degrader Of the LDLR (IDOL), which promotes ubiquitin-mediated degradation of LDLR and inhibition of cholesterol uptake. The overall goal of this project is to test the hypothesis that a recently identified agonist of the nuclear Liver X Receptor, LXR-623, which has been shown to cross the blood brain barrier in humans, will be a highly effective anti-GBM therapy, and to identify the underlying mechanisms by which it works. Specifically, Aim 1 will determine the efficacy of LXR-623 in inhibiting proliferation and inducing cell death in a panel of patient derived GBM neurospheres and secondary metastatic brain cancer cell lines. Aim 2 will determine the mechanism and molecular determinants of LXR-623 antitumor efficacy through both a genetic and a novel sterol probe based unbiased approach, the latter with the Cravatt Laboratory at the Scripps Research Institute who is performing the proteome-wide mapping and activity-based profiling assays to assess the effect of the relevant signaling pathways and the impact of LXR-623 on cholesterol metabolism. Aim 3, in collaboration with the Small Molecule Discovery (SMD) Group at the Ludwig Institute, which has the capability to develop clinical grade compounds and to perform all of the pharmacokinetic studies, will determine if LXR-623 inhibits tumor growth and induces tumor cell death in a patient derived GBM orthotopic xenograft mouse model. Taken together, this study will provide the pre-clinical basis for a phase I clinical trial of LXR-623 patients with GBM and will identify key molecular determinants underlying the effectiveness of LXR-623, providing a new landscape of drug targets in GBM.

Public health relevance
PROJECT NARRATIVE Glioblastoma multiforme (GBM) is the most common primary malignant brain tumor in adults and is among the most lethal of all cancers. Patients have a median survival of 12-15 months despite surgery, radiation and chemotherapy, thus new treatments are needed. This project focuses on testing the efficacy of a brain penetrant Liver X Receptor agonist, LXR-623, which simultaneously inhibits cholesterol uptake and induces cholesterol efflux, and possesses highly potent and specific anti-tumor cell across all GBM cells we have tested. This project is designed to test the efficacy of LXR-623 in patient-derived GBM orthotopic models and to identify the mechanisms of its activity and determinants of its response. It is anticipated that successful completion of this project could lead towards development of LXR-623 as a novel agent for the treatment of GBM patients. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Glioblastoma multiforme (GBM) is the most common primary malignant brain tumor in adults and is among the most lethal of all cancers. GBMs are highly invasive and rapidly develop resistance to conventional therapy [1]. Despite surgery and aggressive treatment with alkylating chemotherapy and radiation, the median patient survival ranges from 12-15 months from initial diagnosis [2]. Minimal improvement in median survival has been achieved in patients with GBM for reasons ranging from the ineffectiveness of drugs traversing the blood brain barrier to the lack of treatments effectively targeting tumor heterogeneity [1]. Therefore, new treatments tailored to the biology of GBM are urgently needed [3]. GBMs, like many other cancer types, are characterized by major alterations in their cellular metabolism, increasing their uptake and utilization of glucose coupled to enhanced lipogenesis to meet the coordinately elevated anabolic and energetic demands imposed by rapid tumor growth. These metabolic alterations and the signaling pathways that control them, appear to be direct consequences of the genetic alterations that drive tumor growth and progression, thus providing a new array of potentially more specific and efficacious drug targets. Dissecting the molecular circuitry by which oncogenes and tumor suppressor losses alter cellular metabolism to support tumor growth and survival, could lead to the development of new, highly specific and more effective GBM treatments. The Mischel laboratory recently discovered that the master transcriptional regulator of lipogenesis, Sterol Response Element Binding Protein 1 (SREBP1), is a key mediator of growth factor receptor-mediated, PI3K-mediated GBM growth and survival [4] and that the mutant form of the epidermal growth factor receptor EGFRvIII, as well as other receptor tryrosine kinases that can activate PI3K signaling, stimulates tumor growth by up-regulating expression of the low- density lipoprotein receptor (LDLR) to promote uptake of massive amounts of cholesterol into the cell [5]. Importantly, we showed that GBM cells rely on primarily on the uptake of exogeneous cholesterol through the LDLR, rather than HMG-CoA-dependent synthesis, suggesting that inhibition of growth factor receptor- dependent, PI3K-dependent upregulation of LDLR could cause massive GBM cell death [4, 5]. Further, we showed, and present here as exciting preliminary data, that agonists of the nuclear Liver X Receptor, including the brain penetrant compound LXR-623, potently kill all GBM cells we have tested, while having no effect on normal human astrocytes, and that this anti-tumor activity is mediated, at least in part, by upregulation of the ATP-Binding Cassette Transporter 1 (ABCA1) to efflux cholesterol from the cell, and by upregulation of the Inducible Degrader Of the LDLR (IDOL), which promotes ubitquitin-mediated degradation of LDLR and inhibition of cholesterol uptake [5]. Our long-term goal is to identify the targetable metabolic circuitry activated by oncogenic signaling in glioblastoma for the development of more effective therapies for GBM patients. The objective of this proposal, which is the next step in pursuit of the long-term goal, is to determine the efficacy, mechanism of action, and molecular determinants of LXR-623 antitumor efficacy in patient derived pre-clinical models of GBM. Our central hypothesis is that LXR-623 is a highly effective anti-GBM therapy and induces cell death by decreasing intracellular cholesterol content, affecting the activity of key cholesterol binding proteins, through induction of ABCA1 and degradation of LDLR. We plan to test our central hypothesis and accomplish the objective of this proposal by pursuing the following three specific aims: 1. Determine whether LXR-623 inhibits proliferation and induces cell death in a panel of patient derived brain cancer cell lines. Based on the supporting data, the working hypothesis for this aim is that LXR-623 will induce cell death in patient derived GBM neurospheres and secondary metastatic brain cancer cell lines. 2. Determine the mechanism and molecular determinants of LXR-623 antitumor efficacy. Based on established knowledge that depriving cholesterol binding proteins of cholesterol can result in cell death [12, 13], and our preliminary unbiased gel based sterol probe profiling analysis identifying changes in the cholesterol protein binding profile of LXR-623 treated GBM cells, we anticipate identifying specific proteins that are mediating cholesterol dependent cell growth and survival in GBM. 3. Determine if LXR-623 inhibits tumor growth and induces tumor cell death in a GBM orthotopic xenograft mouse model. We hypothesize LXR-623 will be effective at inhibiting GBM growth in vivo. The proposed studies are designed to provide critical information needed to move LXR-623 forward for a phase I clinical trial in the future, and to identify key molecular determinants of response to LXR-623 as potential treatment for GBM patients.